Increasing the Social Science Impact of Biomedical Research

Training Core (TL1) - Abstract The objective of the Scripps Translational Science Institute (STSI) TL1 training program is to give pre- and postdoctoral fellows a unique experience in cutting-edge methodological and analytical approaches aimed at making them efficient in the complex arena of translational and precision medicine. This program’s affiliation to a basic research institute instead of a medical school gives it a unique position and strength by offering education in basic research, drug discovery and development, preclinical models, and mechanistic insights into diseases. With a strong emphasis on team science and the integration of attending physicians from Scripps Health in all projects, this program will produce leaders with the skills required to conduct transformative translational science. To date, this young program has trained only predoctoral fellows. All 8 who have graduated, publishing 31 papers in the process, have remained in science, and 6 students remain supported by the program. Based on this success, and after thorough analysis of what bottlenecks remain in the delivery of efficient translational research, we will implement a series of changes to enhance our program by carrying out 3 specific aims: Specific Aim 1. Expand the current coursework to deliver cutting-edge clinical-translational research competencies and enhance mentorship. This objective will be achieved by adding new courses aimed at addressing the most current scientific and medical issues. Mentorship will be reinforced by coordinating each project around monthly meetings with presentation of progress. Specific Aim 2. Expand the current TL1 program to provide the full representation of trainees necessary for successful clinical-translational projects. In addition to our successful predoctoral program, we will include a 3-year postdoctoral pathway to add translational competencies beyond PhD completion. Specific Aim 3. Increase diversity in our training program. Precision medicine cannot be achieved without an acute perception of diversity. Our efforts will be targeted at increasing the number of underrepresented students in our program by adding recruitment relationships with colleges and graduate schools serving these populations. These changes and evolution of the program come at a remarkable time with two exciting developments at TSRI: the integration of the California Institute for Biomedical Research (Calibr) a drug-discovery and development institute that will allow training of TL1 students in that field, and the creation of a Scripps Research Biosciences College in 2018.

Public health relevance
Training Core (TL1) - Narrative Biomedical researchers receive little training in the sociocultural and environmental impacts on human health, inspiring the design of an innovative, new course, The Social Science Impact of Biomedical Research. This course will provide TL1 trainees with a basic understanding of social determinants of health, community stakeholder identification, community engaged research methods, and multidisciplinary team science that includes the expertise required to fully identify social and environmental barriers contributing to unmet health care needs. Through this course, translational research trainees will be better equipped to incorporate social science information and methodology toward translating their biomedical discoveries into inclusive research studies more likely to provide positive health outcomes in all populations.